Mount Sinai Health System Kidney Precision Medicine Project

Project Summary
Forty million Americans live with kidney disease and this number is projected to increase with rising rates of
CKD comorbid conditions, including diabetes, obesity, and hypertension, superimposed on an aging patient
population. A tremendous financial burden is imparted by dialysis therapy and kidney transplantation for end-
stage CKD. At present, however, there are limited tools in existence to predict the progression of AKI and
CKD, and development of therapies has been disappointingly restricted. The overall objective of this
application is to establish the Mount Sinai Kidney Precision Medicine Project (KPMP) recruitment site in
support of the larger consortium’s tissue interrogation and phenotyping activities. There is a tremendous need
to utilize human kidney tissue as a research tool for the identification of AKI and CKD disease markers to
elucidate molecular pathways that contribute to kidney disease development and progression. We have
proposed three Specific Aims: Aim 1 will establish a robust system of patient centered oversight to recruit
diverse patients into a kidney biopsy cohort while maintaining the highest standards of safety, quality and
ethical research conduct. In Aim 2 we will recruit and retain a spectrum of patients with CKD in response to
KPMP priorities. This includes leveraging existing institutional risk stratification tools and resources to identify
and recall patients at risk for CKD progression due to diabetes, hypertension, prior COVID-19 infection and
apolipoprotein L1 associated disease. Aim 3 will recruit and retain patients with AKI as well as those at high
risk for AKI identified by a machine learning algorithm. These Aims overseen by a stakeholder board and
executed by an experienced multidisciplinary team, will integrate with the KPMP consortium to accomplish its
transformative aims.

Public health relevance
Project Narrative Acute kidney Injury (AKI) and chronic kidney disease (CKD) impose a significant health burden worldwide, yet there is limited understanding of the injury pathways leading to these disorders. This has hampered the development of targeted therapies. The Mount Sinai Kidney Precision Medicine Project proposal seeks to recruit a diverse cohort of 40 patients with CKD and 20 patients with AKI each year over a 5-year period into a longitudinal biorepository and database of clinical and phenotypic data.